The role of the Foxi3 transcription factor in craniofacial microsomia

PROJECT SUMMARY
Craniofacial abnormalities are some of the most common birth defects. Although cleft lip and/or palate and
craniosynostosis are the most common craniofacial defects, craniofacial microsomia (CFM) is estimated to be
the third most prevalent cranial anomaly, occurring at between 1 in 3000 – 1 in 6000 live births. Although the
symptoms of CFM can vary widely in severity, they share a variety of features consistent with abnormal
development of first and second pharyngeal arches, including a shortening of the mandible, microtia,
preauricular tags and epibulbar dermoids. These defects are typically, but not exclusively unilateral, and
although some families presenting with CFM have been identified, most are considered sporadic and have no
genetic diagnosis. Difficulties in understanding the origins of CFM include its heterogeneity, the lack of clear
underlying molecular mechanisms and the paucity of good animal models for these disorders.
We have identified a transcription factor, Foxi3, that is expressed early and broadly in pharyngeal ectoderm
and endoderm, and is later restricted to the pharyngeal pouches and clefts. Foxi3 mutant mice show severe
defects in most pharyngeal arch derivatives – for example, the mutants lack much of the lower jaw, and have a
complete loss of the middle ear ossicles and the external ear. Recently, our colleagues found over 20 human
variants in Foxi3 associated with craniofacial defects including CFM and microtia, and our preliminary data
suggests these defects can be modeled in mice carrying some of these variants. Moreover, the Gata3
transcription factor, which has been associated with CFM in genome-wide association studies, is co-expressed
with Foxi3 in several developing cranial tissues and has also recently been shown to cause CFM phenotypes
when mutated in mice. This raises the possibility that Foxi3 and Gata3 interact genetically during craniofacial
development.
In this proposal, we will first attempt to create a mouse model of CFM using Foxi3 mutant alleles created in our
lab and Gata3 mutant alleles characterized by our collaborators. Second, we will perform a bioinformatic
analysis of the gene regulatory networks controlled by Foxi3 and Gata3, by analyzing gene expression in
pharyngeal tissue from Foxi3 homozygous mutants, heterozygous mutant and wild type mice, and by
performing CUT&RUN on pharyngeal tissue to identify direct targets of Foxi3 and Gata3. Finally, we will
address the role of Foxi3 during early craniofacial development by performing conditional deletions of Foxi3 in
pharyngeal ectoderm and endoderm and determining its contribution to normal craniofacial development in
each tissue.

Public health relevance
PROJECT NARRATIVE Craniofacial microsomia is one of the most common birth defects that affects the face. We have identified a gene, Foxi3, that can cause craniofacial microsomia in both humans and mice. We will use mouse genetics to test the contributions of Foxi3 to craniofacial microsomia, and we will create models of human Foxi3 mutations in mice to understand the signals that are disrupted during fetal development in individuals with these birth defects.